Project 3

Pilot and Feasibility Project Summary/Abstract
The overall goals of the Pilot and Feasibility Program are to provide funding for young investigators who have
received no prior NIH project grant support, to attract new investigators into the field of kidney disease
research, and to foster translational and clinical studies directly related to kidney diseases. To achieve these
objectives, the Pilot and Feasibility Program will pursue the following specific aims:
1. Provide support for Pilot and Feasibility Grants of $40,000 per year in direct costs up to 2 years
2. Disseminate announcements of the availability of Pilot and Feasibility Grants in advance of each
application cycle
3. Provide a review process to evaluate the eligibility of applicants, scientific merit of the proposed projects,
and budget justification
4. Monitor progress of funded projects
5. Provide mentoring to grant recipients who are young investigators